OurChild: A Health IT Solution to Reduce Minority Health Disparities

Project Summary/Abstract
Mental health and developmental disorders begin early in life, are prevalent, impairing, and predict mental
health and health challenges in later childhood and in adulthood. One in nine preschoolers has an impairing
mental health disorder, yet less than 15% receive any treatment. In immigrant communities, the disparity
between mental health needs and care is greater because of cultural and language barriers, limited mental
health literacy, and decreased use of health IT solutions, like Electronic Health Record (EHR) patient portals.
Chinese American immigrant families are a fast-growing immigrant group with unmet early childhood mental
health needs. We propose to design, build, and implement OurChild, an integrated mHealth/EHR solution
to increase access to early childhood mental health knowledge and mental health services and
resources for Chinese American children ages 2-6 years old and their parents in Sunset Park,
Brooklyn. Our proposal unites our longstanding partnership with the Chinese American community in Sunset
Park and the safety-net clinics serving it with our team's 1) clinical and scientific expertise in health disparities,
participatory research and early childhood mental health and 2) the digital health/health IT expertise of the
WonderLab, a digital incubator in the NYU Langone Department of Child and Adolescent Psychiatry. Our goal
is to reduce health disparities by explicitly designing a digital solution that facilitates connection and
bidirectional exchange of information across the cultural, contextual, language, and setting differences that are
key barriers to early childhood mental health knowledge and access to care for this immigrant population. Our
first aim is to iteratively design, build, and test OurChild. To do this we will 1) collaborate with our family,
clinical, and community stakeholders to conduct an early childhood mental health context/needs analysis and
participatory design and discovery activities; 2) use these insights to adapt and user-test iterative prototypes;
3) evaluate the usability and acceptability of a beta version of OurChild in a mixed-methods pilot with 20
Chinese American parents and their 2- to 6-year-old children who receive care at the Sunset Park 7th Avenue
Family Health Center; and 4) optimize the design, features, and performance to create OurChild 1.0.Our
second aim it to evaluate the Reach, Effectiveness, Adoption, and Implementation of OurChild 1.0 with a 6-
month longitudinal implementation cohort study with 200 parent/child dyads. We will use a mixed-methods
approach using metadata collected with the OurChild app, parent-reported data from the app, EHR data, and
post-implementation focus groups with providers to determine whether use of Our Child increases referrals of
young children for a mental health consultation or evaluation (Primary Aim). Our secondary aims will examine
whether use of OurChild 1) increases parent self-efficacy; 2) parent–provider engagement; and 3) linkage with
community early childhood resources. Both OurChild and our digital methodology will be designed to be scaled
to other Chinese populations and efficiently adapted for other health disparity populations.

Public health relevance
Project Narrative OurChild is a digital platform that links an in-home smartphone app (available in Chinese and English) with the electronic health record to improve access to mental health knowledge and care for Chinese American young children and their families. Parents collect information about their child’s mental health and receive real-time actionable insights and resources. Clinical information is automatically shared with the child’s doctor to improve referral to mental health services, parent-provider engagement, and linkage with clinical and community services.